Administrative Core-UM First

PROJECT SUMMARY
The goal of the proposed UM FIRST program is to catalyze institutional change through the
recruitment of URM faculty with a stated interest in diversity, equity, and inclusion. A
collaboration between the University of Maryland School of Medicine (UMSOM) and the
University of Maryland Baltimore County (UMBC) will capitalize on the strengths of each
institution in developing and maintaining inclusive programs to encourage diversity in the
biomedical research workforce and developing NIH-funded faculty from junior investigators,
respectively. The role of the Administrative Core is to ensure the program activities are effective
and well-integrated across both institutions through collaboration with the Faculty Development
and Evaluation Cores, oversee sound fiscal management through a team-based plan that will
ensure strategic deployment of resources, recruit a diverse cohort of new faculty by capitalizing
on a series of novel activities that will transform search and recruitment practices at both
institutions, and implement new institutional policies and procedures that codify the importance
of a diverse faculty and provide an embracing infrastructure that leads to sustainable
institutional change.
The Administrative Core will span both institutions and will be directed by the PIs and Co-Core
Leaders, Drs. Kaper and LaCourse, and Co-Directors, Dr. Prasad and Ms. Johnson. Additional
oversight and guidance will be provided by the Program Steering Committee and the Fiscal
Oversight Committee, as well as the Internal and External Advisory Boards.

Public health relevance
The University of Maryland School of Medicine (UMSOM) and the University of Maryland Baltimore County (UMBC) are submitting a joint application to the NIH Faculty Institutional Recruitment for Sustainable Transformation (FIRST) program to recruit new faculty members from groups traditionally underrepresented (UR) in biomedical research. This consortium will use a model for faculty development and promotion that is based on the UMBC Meyerhoff Scholars Program, which has been highly in training undergraduates from UR groups who have gone on to careers in STEM (Science, Technology, Engineering, Medicine). The model will feature cluster hires of 10 new faculty in the areas of cancer biology, neuroscience and microbiology/immunology/infectious diseases, in which there is great institutional strength.